Encouraging Excellence: Health Science Education in Native American Communities

The University of Nebraska Medical Center will continue to leverage the trust and cooperative spirit that we have garnered working with tribal schools and communities in Nebraska and South Dakota to develop, implement, and evaluate science curriculum, outreach activities, and training experiences targeting Native American students in grades K-12 and their teachers. The long-term goals of this project are to promote student interest in the sciences, foster a more science-literate public, and ultimately increase the number of Native Americans entering health and science careers. Advancing the health of Native American communities is the ultimate aim of every aspect of this project. Improved science teaching and heightened awareness of health careers will encourage students to enter these careers and hopefully bring these skills back to their communities. Public outreach that increases health literacy and healthy living will promote better personal health decisions. This supplement request seeks to expand our SEPA program to provide directed academic preparation to middle and high school students from our Native community partnerships. Since the end of the 2019-2020 academic year and virtually all the 2020-2021 academic year, students have undergone a mixture of in-person, virtual, and sometimes no-learning. In some cases, grading was suspended, which did not provide incentives to learning. Here will propose to establish learning clubs with several hardest impacted partners to ensure that students are prepared to be successful in high school and college.

Public health relevance
Educational programs to underserved communities serve many purposes. As we begin a return to normalcy and students return to in-school learning, there is a fear that students will not catch up to pre-pandemic academic achievement. This supplement will help to provide academic enrichment activities to middle and high school students and their teachers. These activities will help to bridge the significant gap in health and education disparities in Native American populations.